Core A: Administrative Core

ADMINISTRATIVE CORE: PROJECT SUMMARY/ABSTRACT
The overall theme of the “3-D Aging & Alzheimer Brain Program” is to is to define the effect of multiple pathologies
on the aged brain in three dimensions by combining single cell-based approaches with spatially-resolved
transcriptomic and proteomic measurements. To accomplish this goal, the Program has been organized into four
cores and four research projects, each with their own individual goals whose complexity and ultimate
interconnection requires careful coordination and oversight. Central to this effort is the Administrative Core
(Admin Core), which will serve as the organizational hub for our Program, providing an umbrella of scientific
oversight, coordination, and support for the Program activities. The Admin Core will be led by the Program
Director, Dr. Philip De Jager, who will be responsible for overseeing the day-to-day operations with support from
a project coordinator and an administrative assistant. Together, they will provide support for administrative and
financial activities, as well as manage all internal and external communications, including those with the National
Institute on Aging (NIA). To ensure scientific oversight of the Program, the Director will chair the Steering
Committee, which will be composed of Core and Project Co-Leads, as well as relevant NIH staff. The experience
of the Steering Committee members will be leveraged to establish a Charter and to set attainable deliverables
at the onset of the Program. Additionally, the Steering Committee will meet monthly to coordinate and ensure
that the overall goals of the Program are being achieved. The Steering Committee will work closely with the NIA
to assemble an External Advisory Board (EAB), which will annually evaluate the Program and provide external
oversight. The Admin Core will develop and implement a state-of-the art Laboratory Information Management
System (LIMS) to ensure appropriate tracking of specimens and data between the Program components. The
Admin Core will also be responsible for ensuring compliance with the Program’s resource sharing plan in order
to maximize access to the resources generated by the Program. This will be facilitated via a collaboration with
Sage Bionetworks in order to oversee distribution of all Program data and resources via the NIA-sponsored
repository, AD Knowledge Portal. The Admin Core will organize a quarterly educational meeting focused on the
techniques and best practices implemented via this Program. To help promote awareness of Program resources
and scientific activities, the Program will participate in and host an annual research symposium and establish an
outward-facing website. The Admin Core is designed to provide research and logistical oversight and facilitate
communication among all Program components to enhance efficiency, reduce cost, and maintain the timely
achievement of milestones. The proper dissemination of Program-generated resources to the scientific
community will fill the large gap in knowledge regarding the 3-dimensional modeling of molecular events in the
aging brain and the impact of neuropathological features.